Functions of skeletal muscle mineralocorticoid receptor signaling in chronic and acute injury

PROJECT SUMMARY
Mineralocorticoid receptor (MR) antagonists (MRAs) have long been considered as anti-fibrotic drugs for
treatment of heart failure. Although MRAs also have therapeutic benefits on skeletal muscle pathology in
mouse models of Duchenne muscular dystrophy (DMD), their effects on skeletal muscle fibroblasts have never
been defined. Fibroblasts produce extracellular matrix proteins that constitute fibrosis that replaces muscle
tissue that leads to loss of ambulation, respiratory insufficiency and cardiomyopathy in DMD. Both MRAs and
genetic deletion of MR in myofibers lead to reduced fibrosis in dystrophic models. In contrast, deletion of MR
from myeloid cells increases fibrosis in dystrophic muscles. These data support the overall hypothesis that MR
signaling has complex cross-talk between cell types in the injured muscle microenvironment that ultimately
regulates fibrosis. The endogenous MR agonist aldosterone increases proliferation and migration of cardiac
and renal fibroblasts, which is prevented by MRAs. Recent data support that fibroblasts differ between organs,
preventing extrapolating conclusions from one tissue to another. In addition to its role in disease, fibrosis is
essential for homeostasis of organ structure and wound healing. MRAs reduce the kinetics of acute injury
repair in normal muscle, supporting a normal role for MR signaling in skeletal muscle wound healing. In this
application, we will identify fibroblast regulation through non-fibroblast MR signaling and directly through
fibroblast MR signaling in muscle wound healing and muscular dystrophy. We will compare molecular
signatures, proliferation, migration, and activity between fibroblasts isolated from dystrophic mice treated with
MRAs or untreated. We will compare these mechanisms in more fibrotic dystrophic diaphragm with less fibrotic
limb muscles. To define mechanisms of MR signaling in essential fibrosis during wound healing versus chronic
fibrosis during disease, we will compare fibroblasts isolated from mice with myofiber and myeloid MR
knockouts in dystrophic muscles and in acutely injured wild-type muscles. Single-cell RNA-sequencing will be
used to identify MRA effects on mononuclear cell populations in acute injury versus dystrophy. We will perform
co-culture and conditioned media experiments with MR knockout and control myeloid cells or myotubes with
fibroblasts to identify MR-regulated cross talk between these cell types. Direct MR signaling in skeletal muscle
fibroblasts, different signaling in resolving fibrosis in wound healing versus chronic fibrosis in dystrophy,
between dystrophic muscles with different fibrosis levels, or between young and old muscles have never been
studied. Fibroblasts isolated from young and old mdx diaphragms and limb muscles and acutely-injured wild-
type muscles will be treated with increasing dosages of aldosterone with or without an MRA and gene
expression, proliferation, migration and activity will be compared. A fibroblast specific MR knockout will be
generated for in vivo validation. These studies will define direct and indirect effects of MRAs on muscle
fibroblasts to optimize MR modulation for DMD, other muscle diseases and possibly for acute muscle injuries.

Public health relevance
PROJECT NARRATIVE FDA-approved mineralocorticoid receptor (MR) antagonists (MRAs) have clinical benefits for cardiomyopathy in Duchenne muscular dystrophy (DMD) patients and preclinical benefits on skeletal muscle pathology. However, their effects on skeletal muscle fibroblasts, the cell type involved in deleterious fibrosis, have not been defined. This application will define direct and indirect effects of MRAs on fibroblasts to optimize MR modulation for DMD, other muscle diseases and for muscle injuries.